MARK1 in dendritic spine neoteny

Project Summary
A key cellular substrate underlying learning and memory is the plasticity of dendritic spines, which are
sites of excitatory synaptic inputs in the mammalian brain. Dendritic spines show protracted synaptic
maturation during human brain development, leading to longer spines with higher density in adulthood as
compared with rodents. This extraordinary neoteny of spines is believed to underlie the high cognitive
performance in humans. However, there remains a dearth of knowledge regarding the molecular
mechanisms that contribute to dendritic spine neoteny unique to humans. One way to approach this
issue is to examine genes that show adaptive evolution along the human lineage. These genes are under
positive selection pressure and are likely to play a role in human speciation. In particular, genes that show
adaptive evolution and genetically linked to neurodevelopmental disorders are strong candidates that may
contribute to the high cognitive capacity of the human brain. To date, there are only a handful of genes
reported to fit both criteria. One of the genes encodes the Microtubule Affinity Regulating Kinase 1 (MARK1), a
Ser/Thr kinase highly expressed in the brain. MARK1 displays strong evidence of adaptive evolution in the
lineage leading to humans, and single nucleotide polymorphisms (SNPs) of MARK1 are associated with autism
spectrum disorders (ASD) and bipolar disorder. We previously found MARK-mediated phosphorylation of the
synaptic scaffolding protein PSD-95 is important for bidirectional dendritic spine plasticity. Moreover, our
preliminary studies show loss of MARK1 in forebrain pyramidal neurons leads to reduced spine formation and
delayed spatial learning. In addition, we observed a significant increase in the synaptic levels of the AMPA
receptor subunit GluR2 in the MARK1 conditional KO (cKO) hippocampus. By contrast, in neurons where
rodent MARK1 was replaced with human MARK1, we observed increased spine density and immature
morphology reminiscent of human neurons. These exciting data led us to hypothesize that loss of MARK1
leads to premature dendritic spine stabilization, which limits spine density and impairs learning.
Conversely, human MARK1 shows enhanced kinase activity leading to dendritic spine neoteny and
increased spine density, which contributes to high cognitive functions in humans. Aim 1 will test the
hypothesis that human MARK1 contributes to spine neoteny through regulating the PSD scaffold and GluR2
trafficking. Aim 2 will test the hypothesis that altered spatiotemporal dynamics of human MARK1 activity is
responsible for its effects on spine neoteny. We will utilize FRET, FRAP, super resolution imaging, and two-
photon glutamate uncaging. We will complement these imaging approaches with biochemical analyses and
optogenetic manipulation of MARK1 activity. Completion of the proposed experiments will establish a role for
MARK1 in dendritic spine neoteny observed in human neurons. The results can shed light on the molecular
mechanisms underlying high level cognitive functions of the human brain.

Public health relevance
Project Narrative There is a dearth of knowledge regarding the molecular basis underlying the high cognitive functions unique to the huma brain. In this study we focus on a specific gene that shows accelerated evolution in the human lineage. We will examine how the human and rodent versions of the gene differentially affect the connectivity between neurons.